Administrative Core

Administrative Core – Abstract
The Administrative Core (AC) led by MPIs Dong and Wu, with more than 10 years of successful collaboration,
will play a central role in organizing, integrating, and managing multi-institution resources to maximize the overall
productivity of our proposed Rutgers-NYU Center for Asian Health Promotion and Equity (CAHPE). This AC
includes: Recognized experts and leaders in health disparity, intervention, prevention, cardiometabolic, and
mental health research across Asian populations with strong records in productivity, leadership, and mentorship;
2) Significant resources through Rutgers/NYU/Hunter CUNY; 3) A well-designed team science infrastructure to
support Pilot and Center Research Project investigators; 4) Strong and broad connections to practice and policy
and the community, state, and national levels. The AC leaders Drs. Dong and Wu, along with the assembled co-
investigators, executive committee, external advisory committee, and community advisory board have extensive
experience successfully conducting health equity translational research on prevention, treatment, and
management of cardiometabolic and mental health disease outcomes among Asian populations through a
cultural lens, as do other members of the center faculty. Resources and support will come from substantial
institution-wide infrastructure that will provide steadfast support in accomplishing our CAHPE mission.
The AC will establish mechanisms and infrastructure that promote community, interaction, and integration
to allow Pilot and Center Research Project investigators to work synergistically on their projects. The AC will also
ensure that Pilot and Center Research Project investigators have full access to the time and experience of the
transdisciplinary core faculty, both individually and in group settings across Rutgers/NYU. The AC will collaborate
with the Executive Committee, External Advisory Committee, and Community Steering Committee to integrate
the interdisciplinary research through the perspective of academic, community, state, and national leadership.
The AC will provide strong leadership along with the infrastructure and administrative support needed to
orchestrate the Investigator Development Core, Community Engagement Core, and 3 Research Projects into an
integrated center and take advantage of the rich environments at Rutgers and NYU. AC specific aims are: 1)
Oversee all Center for Asian Health Promotion and Equity activities, ensure effective implementation and fiscal
administration and create and sustain mechanisms; 2) Maximize and coordinate use of resources and provide
mechanisms for interactions and data harmonization between Pilot and Center Research Project investigators,
researchers, and colleagues across Rutgers, NYU, the P50 Coordinating Center, and NIMHD Centers; 3)
Provide oversight and support to enhance the success of the Pilot program and track and evaluate investigators;
and 4) Provide systematic, objective, and formal evaluation of each core and the Center as a whole using
established benchmarks and regular feedback about Center activities in order to iteratively improve the Rutgers-
NYU Center for Asian Health Promotion and Equity.